The Training and Outreach Core

The Training and Outreach Core
We propose to create a new “Training and Outreach Core'' which will take advantage of the multidisciplinary scientific directions and technologies represented by our team, as well as the unique properties of the larval zebrafish as model organisms for outreach and training. The mission of this core is to enhance the efficiency of training for the next generation of scientists and to optimize the process of educating and tutoring trainees in scientific research. This mission will be carried out by three interlaced programs - Summer Connectomics Internship for Outreach Neuroscience (SCION), BioBus, and Postbac Life Science Fellowship (PLSF). The SCION and PLSF programs integrate students with the U19 research projects and shape them into competent scientific contributors through an active learning framework. The two programs lower the barrier to science research by identifying and engaging particularly talented students who do not have research experience and who would otherwise not consider scientific research. SCION’s primary goal is the recruitment of talented and motivated high school and college students as contributors to mapping the zebrafish nervous system, combining citizen science with education and career development. Recruitment of PLSF fellows is merit based, and they will be trained and integrated within a U19 research project with high likelihood of publication. The program places emphasis on work experience and engages postbacs who want to pursue a profession in the life sciences, but lack laboratory experience. The BioBus program interfaces with the local K12 schools to engage middle and high school students with zebrafish neuroscience and to promote STEM education. It serves as a recruitment pipeline for SCION and for the training of postdocs and graduate students as Outreach Fellows. BioBus and SCION both provide frameworks for education and training of graduate students and postdocs in outreach, pedagogy, project management and public speaking. In turn, these pedagogical and mentorship experiences compel the postdocs and graduate students to regularly reevaluate their own research projects, becoming better scientists by teaching.

Public health relevance
The research plan we propose aims at a comprehensive multi-level understanding of how the brain and the body interact to respond adaptively to a potentially harsh and unforgiving environment. Among the many internal factors that are under constant homeostatic regulation, we focus on the bi-directional dialogue between the brain and the heart, since the cardiovascular system and its role in regulating oxygen delivery is one of the most critical and universal control systems within the animal kingdom. A central aspect of our approach is the generation of a complete brain and body connectome of the larval zebrafish, a map which will be the first ever generated in a vertebrate, and which will be critical in both testing the validity of many extant models, and perhaps discovering new pathways within the interconnected neural circuits that serve the changing needs of the body during behavior.